Temporal Epigenetic Regulation in Human Hypothalamic Neurons and Body Weight

ABSTRACT The hypothalamus is the brain hub that regulates energy homeostasis. The genetic and molecular basis of this regulation in humans is not well understood as access to this tissue is a major barrier and available only postmortem. To overcome the barrier of limited tissue access, we are generating induced pluripotent stem cell (iPSC)-derived neuronal cultures that recapitulate many of the features of hypothalamic neurons from the arcuate nucleus, including by benchmarking this in vitro model to in vivo events that are pivotal in hypothalamic development. We will use this human model and state of the art high throughput assays to test our hypothesis that non-coding genetic variants associated with obesity measures and body weight regulation impact on these traits secondarily through epigenetic regulation which is dynamic across hypothalamic development. We will employ genome editing techniques such as CRISPR in our human cells to experimentally assess physiologic effects of variants identified to influence chromatin status of obesity associated loci. The public health impact of all functional variants will then be assessed using data from large, multi-ethnic epidemiologic cohorts. These studies will represent the first attempt at establishing the epigenetic architecture of human hypothalamic neuronal cells and serve as a bioresource for understanding diseases linked to alterations in energy homeostasis. A unique component is the evaluation at multiple time points during development, thus providing a critical catalogue of the human epigenome at stages representing fetal development. We anticipate that the epigenetic map will differ from that in adult brain and will vary temporally. We also anticipate that genes associated with body weight regulation will cluster into distinct chromatin accessibility patterns that differ over time. Discovery of epigenetic mechanisms connected to genetic liability will identify potential underlying factors behind both heritable and diet-induced obesity and potential therapeutic means by which the epigenetic mechanisms that influence disease susceptibility can be reversed.

Public health relevance
PUBLIC HEALTH RELEVANCE Overweight and obesity among the world's population is staggering. According to the World Health Organization (WHO), in 2014, 39% of adults aged 18 years and over were overweight and 13% were obese. In the United States, it has been estimated that more than one-third of adults and 17% of youth are obese. An increase in body weight has also been observed among infants and toddlers from birth to 2 years. In 2011, 7.1% were at or above the 97.7th percentile of sex-specific WHO weight for recumbent length growth charts. This puts millions of individuals of all ages at risk for life threatening disorders such as coronary heart disease, type 2 diabetes, cancers, and stroke. The fundamental cause of overweight and obesity is an energy imbalance which can be the result of genetic susceptibility and environmental influence such as diet and lifestyle. A key organ system that regulates energy balance is the brain hub called the hypothalamus. Neurons within this brain region receive signals regarding energy status and direct the whole body response. Understanding the genetic control of proper development of the hypothalamic neurons as well as any disturbances in function due to hereditary genetic variation may point to new pathways for treatment options and prevention during development.